Technology Core: Sequencing

The objective of this Core is to provide sequencing services to support the other projects in this Program Project in their efforts to determine the functions of proteins in the M. tuberculosis (Mtb) genome. We will take advantage of next-generation sequencing technology (aka

Public health relevance
M. tuberculosis the most prevalent human pathogen worldwide, and a better understanding of the biology of the organism through the functions of genes in the genome is needed for development of new therapies. The goal of this Core is to exploit next-generation DNA sequencing in several ways to provide insight on the functions of genes in the Mtb genome whose funcfions are currently unknown.